Pediatric Fungal Network's (PFN) STudy of Rare Invasive Fungal DisEases in Immunocompromised Pediatric Patients (STRIDE) Project 2

PROJECT 2 SUMMARY/ABSTRACT
Invasive fungal diseases (IFDs) represent a range of infections caused by rare fungi that are opportunistic in
immunocompromised pediatric hosts. While these infections are relatively rare, they are associated with
significant morbidity and mortality. Furthermore, as the care for underlying conditions such as hematologic
malignancies, hematopoietic cell transplantation, solid organ transplantation, and patients with primary or
acquired immune deficiency evolves, the patient population vulnerable to IFD will increase. The World Health
Organization has recently highlighted fungi as a significant force impacting global public health. The WHO
specifically underscored emerging pathogens and those for which antifungal resistance is a concern; fungal
pathogens that are a focus in this proposal. Alarmingly, there is a lack of centralized resources to better
understand the genomics and resistance profiles of these pathogens, information that would help guide
therapeutic approaches and future clinical trials. To our knowledge, there are no large-scale, comprehensive
collections of banked isolates of disease-related fungi that are integrated with genomic, phenotypic, and clinical
data. Our goal is to establish a central biorepository to operationally receive and process rare fungal pathogens
from newly diagnosed IFD cases among immunocompromised pediatric patients as well as isolates banked in
existing fungal pathogen repositories, and establish a system that integrates genomic, phenotypic, and clinical
information. In Aim 1 we will establish this biorepository and produce whole-genome sequences for
approximately 350 fungal pathogens from the four rare IFD groups identified as foci for this proposal. In Aim 2
we will perform comprehensive antifungal susceptibility testing and these phenotypic results will be matched with
genomic and clinical data. In Aim 3 we will quantify cohort-wide genomic diversity, pilot genome-wide association
studies to prospectively identify novel antifungal resistance mechanisms, and directly investigate distribution of
known antifungal resistance variants. This project will establish an innovative biorepository that addresses a
critical gap in rare disease infrastructure and pioneer foundational knowledge for future work on IFD genomics,
resistance, and clinical outcomes.